Effect of dietary restriction on intestinal stem cell aging

Stem cells play a critical role in the maintenance of tissue function with age and retention of their
regenerative capacity is essential to this role. An age-related decline in regenerative capacities
due to loss of stem cell number and function is observed in many tissues. Therefore,
understanding the mechanism(s) that regulates stem cell function is essential for retarding the
aging process and interventions that affect stem cells have the potential to be a target for antiaging
interventions. Dietary restriction (DR) is a robust anti-aging intervention that extends the
lifespan of a variety of organisms and has been shown to prevent the decline in physiological
function. DR has been shown to enhance the function and self-renewal of stem cells in various
tissues including the intestinal stem cells. Studies indicate that both long and short term DR
increases intestinal stem cell number and the ability of the stem cells to regenerate an entire crypt
in vitro. Although DR has been shown to enhance the regenerative capacity of intestinal stem
cells, the mechanism underlying this effect remains unknown. DNA methylation has been shown
to have a critical role in stem cell proliferation and differentiation. More importantly, DNA
methylation drift has been associated with stem cell aging. Based on these key studies and our
recent preliminary data, we hypothesize that, DR increases the expression of genes involved
in ISCs proliferation and differentiation by inducing changes in DNA methylation at
specific genomic sites of the ISCs. Further, we propose that short term DR will reverse the
age-related decline in stem cell aging by modifying both DNA methylation and gene
expression. We will test our hypothesis through these aims: (i) Identify DNA methylation
changes induced by DR in the ISC genome (ii) Identify key genes that play a role in DR’s effect
on ISC function.